Prediction of interval breast cancer risk using genetic variants

Project Summary/Abstract
This is a resubmission of a K08 award application for Dr. Yiwey Shieh, a general internist at the University of
California, San Francisco (UCSF). Dr. Shieh’s long-term career goal is to become a leading clinician-
investigator working at the intersection of precision medicine and cancer screening/prevention. This K08 award
will provide Dr. Shieh with the support necessary to: 1) develop an understanding of breast cancer biology and
tumor gene expression profiling, 2) expand his analytical skills in genetics and prediction modeling, 3) obtain
the skills needed to conduct late-translational studies on personalized cancer screening, and 4) build an inde-
pendent research career. To help him achieve these goals, Dr. Shieh has assembled an exemplary team of
mentors with complementary expertise. Dr. Elad Ziv, a leading cancer genetic epidemiologist, will serve as the
primary mentor and oversee completion of research aims and training goals. Co-mentors include: Dr. Laura
van’t Veer, an expert in gene expression analysis of breast cancer; Dr. Mi-Ok Kim, an expert in biostatistical
methods and study design; and Dr. Laura Esserman, a breast surgeon and leading innovator in precision on-
cology. The proposed work will benefit from the available expertise and rich institutional environment of UCSF,
specifically the Helen Diller Family Comprehensive Cancer Center, one of the top cancer centers in the coun-
try. Dr. Shieh will leverage the above resources to address an important problem in cancer control, namely the
limited ability of current breast cancer screening strategies to detect biologically aggressive cancers. These
cancers tend to present symptomatically following a normal mammogram as “interval cancers”, and often at
advanced stages. Dr. Shieh’s past work has focused on predicting overall breast cancer risk using clinical risk
models and polygenic risk scores (PRS) representing the combined effects of multiple single nucleotide poly-
morphisms (SNPs). Dr. Shieh proposes to adopt this approach to construct a risk model for interval cancers
based on preliminary data suggesting that previously discovered SNPs may hold additional prediction for
breast cancer phenotype. Given the ability of gene expression profiling to provide detailed tumor phenotypic
information, Dr. Shieh proposes to identify gene expression signatures correlated with rapidly-developing (ag-
gressive) interval cancers (Aim 1). Dr. Shieh will then use these gene expression signatures to select SNPs
associated with aggressiveness (Aim 2). These selected SNPs will be used to construct a PRS for aggressive
cancer. Finally, Dr. Shieh will test the ability of this PRS to predict interval cancers, both alone and in combina-
tion with breast density and clinical risk factors (Aim 3). The proposed aims will leverage Dr. Shieh’s unique
access to data from clinical trials, tumor atlases, and breast cancer screening cohorts. The results will directly
lead to subsequent studies on using an interval cancer risk model to prospectively inform screening and pre-
vention, as well as studies on the role of novel biomarkers in refining risk stratification among high-risk women.

Public health relevance
Project Narrative Between 20-30% of women undergoing screening mammography develop a symptomatic breast cancer follow- ing a normal mammogram; these interval cancers are often biologically aggressive and associated with worse outcomes. The proposed research will develop a risk prediction model for interval cancers using genetic vari- ants, breast density, and clinical risk factors. This tool could enable personalized screening and prevention ap- proaches that are specifically tailored to a woman’s risk of aggressive cancer, potentially decreasing morbidity and mortality related to interval cancers.